Administrative Core

Administrative Core
Summary
The primary goal of the Administrative Core is to provide logistical, organizational, and managerial support for
this Biomarker Characterization Center (BCC) and foster the interaction of the BCC with the other EDRN team
members and Centers, including BCCs, CVCs, the DMCC, and the NCI. As current BDL and BRL grantees
from JHU, we will build on the effective communication and coordination strategies in place to form an
integrated BCC that works effectively with all EDRN Centers and aligned with NCI goals and priorities. We will
have a strong base of support from the experienced investigators and an internal framework to ensure
integrated operations of the BDL and BRL components, adherence to project and network milestones and
timelines, and overall project success. We will work to ensure the success of the entire EDRN program and will
participate in the EDRN Steering Committee, and EDRN meetings and teleconferences. The Administrative
Core will collaborate, interact, and ensure bidirectional exchange of findings and insights with the other EDRN
BCC, CVC, and DMCC team members. We will also provide resources and support for the validation of
biomarkers developed by the EDRN, and ensure participation in collaborative projects with other laboratories
and centers. In summary, we will leverage the robust leadership structure and collaborative-team work
experience of the proposed BCC to facilitate realization of the overall goals of the EDRN and ensure the
success of BDL and BRL.